Clinical field study to evaluate the safety and effectiveness of Canalevia to treat chemotherapy-induced diarrheal in dogs

7. Project Summary/Abstract
Chemotherapy-induced diarrhea in dogs (CID) continues to be a common adverse drug event
experienced by many dogs undergoing chemotherapy treatment. CID is an even greater threat
today with the advent of the newer target agents that effectively kill the cancer but can cause the
dog to suffer from severe enough diarrhea to be dehydrating and life-threatening and may require
reduction or discontinuation of the use of the targeted therapy.
The long-term objective of this research is to design and develop a clinical field study that will
demonstrate substantial evidence of effectiveness of Canalevia®-CA1 in the treatment of
chemotherapy-induced diarrhea (CID) in dogs. A successful field study is the final step to
acquiring full approval of Canalevia from CVM, which will ensure that this product will remain
on the market to combat CID in dogs.
A total of 240 dogs with a history of CID will be recruited to join the study by their veterinary
oncologist during their next regularly scheduled chemotherapy visit. Dog owners will be trained
on the use of the Purina Fecal Scoring (PFS) system and on the use of the IWRS cloud-based
data capture system that they will download to their mobile telephone or tablet. After returning
home, if their dog develops CID, the dog owner will begin twice daily dosing with masked study
medication for 3 days, and also begin recording all PFS fecal scores using the IWRS system.
Biological samples will be collected at the time of enrollment and again at study end to assess
clinical pathology parameters for safety.
The expected outcome of this study is a statistical as well as a clinical significance in the
superiority of Canalevia to successfully treat CID in dogs vs. placebo, which would allow us to
submit the NADA to CVM for full approval of Canalevia to treat CID in dogs. There is no other
product on the market that is approved to treat CID in dogs, so gaining full approval of Canalevia
through a successful clinical study will ensure that Canalevia remains on the market to be
available for the treatment of CID in dogs.

Public health relevance
8. Project Narrative The development of crofelemer as a therapeutic agent for chemotherapy-induced diarrhea (CID) in dogs is of paramount importance due to the lack of any effective CID therapies in dogs. With the advent of the newer targeted cancer therapies, the incidence of CID in dogs is greater and more severe than ever and demands an effective treatment for this dehydrating and potentially life-threatening condition of CID. Dogs undergoing cancer treatment are beloved family members that deserve to have dignity and a good quality of life while dealing with cancer and the harsh therapies often involved with cancer therapy.